Harvard TH Chan Education and Research Center for Occupational Safety and Health

Project Summary
The Harvard Education and Research Center’s primary objective is the training of leaders in occupational
health and safety specialties. The ERC comprises several academic and research cores: industrial
(occupational) hygiene, occupational medicine, occupational epidemiology, and targeted research training.
Through a combination of practical and research-oriented coursework and field experiences, graduate students
at the Center examine current problems relating to the workplace and learn methods and approaches for
establishing health and safe work environments. Our goal is to prepare our students and trainees to be
national and international leaders for improved understanding and prevention of work-related
disease through research and practice. The Master’s program in Occupational (Industrial) Hygiene includes
didactic and internship placements, allowing rapid entry to industry. Physicians training in the Occupational and
Environmental Medicine Master of Public Health and Residency programs are educated and trained for clinical
practice OHS management and leadership, and academia. The HSPH ERC offers a variety of doctoral
preparation in Occupational Epidemiology, Occupational Hygiene, and Targeted Research Training, with
curriculum tracks that cover the gamut of OHS disciplines. The Occupational Epidemiology Program Area
confers doctoral degrees in population aspects of occupational health and safety. In addition, our Targeted
Research Training Core aims to groom the future generation of faculty and professional trainers with doctoral
and post-doctoral tracks. Further, the Targeted Research Program aims to provide trainees with
interdisciplinary research education and experience in cutting-edge research projects designed to address
NORA priorities and research-to-practice (r2p). The Pilot Project Research Training Program also makes
awards in the region to support graduate trainees in occupational health and safety in research responsive to
NORA priorities. Finally, the programs in Continuing Education and Outreach are dynamic and creative efforts
at serving the occupational safety and health needs of New England and providing an integrative force to link
the community. The Continuing Education Program, in collaboration with the Center and the School’s Office of
Continuing Professional Education, offers an impressive slate of courses that meet regional and national
needs. The Outreach Program has been successful in impacting the curriculum of other schools of higher
education within the region, establishing a network of professionals in New England who are interested in
occupational safety and health.

Public health relevance
Narrative: Overall PUBLIC HEALTH RELEVANCE: The Harvard Chan ERC plays a vital role in the New England region as well as the nation in providing interdisciplinary education and training for graduate-level professions in key disciplines of occupational health and safety. This work is complemented by continuing education and outreach efforts in these key disciplines. The Center produces researchers and practitioners vital to maintaining workplace health and safety.